Pharmacokinetics (Florida)

DMPK CORE The DMPK core provides enabling technologies and capabilities to support the discovery of new chemical entities, ranging from in vitro ADMET assays to in vivo pharmacokinetics in rats and mice. In vitro assays include measures for cell permeability, protein binding, metabolic stability, and drug-drug interaction liabilities. The DMPK group at Scripps Florida currently occupies approximately 1000 sq/ft of laboratory and the office space housed in a 41,000 sq/ft research facility in Jupiter, Florida. Animal services are provided in a new stateof- the-art facility of approximately 5,000 square feet with the capacity to house approximately 1500 mouse and 240 rat cages. The Vivarium includes animal quarantine and holding rooms for rodents, dedicated procedure space, and a biosafety level 3 (BSL3) containment suite with shower-in requirement, biosafety cabinets, ventilated racks, and pass-through autoclave. Animal services are provided by a fully trained staff with a contract veterinarian.